S100A4 mediated immune suppression in GBM

Project Summary
Glioblastoma (GBM) is the most common and aggressive malignant brain tumor in adults and is virtually
incurable. Despite aggressive treatments that include surgery, radiation therapy, and chemotherapy, the average
survival is 15.4 months, with less than 5% of patients surviving > 5 years. Immunotherapy is a promising new
approach to treat GBM as it harnesses one’s own immune system to recognize and kill aberrant cancer cells.
Unfortunately, ongoing trials with immunotherapies show disappointing results in most GBM patients, indicating
that we need to better understand the intricate and dynamic interactions between glioma and immune cells that
generate and maintain highly immune suppressive microenvironment in GBM.
The major goal of this application is to test our hypothesis that S100A4 is a critical regulator of the GBM
immune landscape. S100A4 is a small calcium binding protein that functions intracellularly as well as
extracellularly. We recently reported that S100A4 is necessary for human and mouse glioma stem cell self-
renewal. Our single cell RNA-sequencing analyses of human GBM shows that S100A4 is expressed in both
glioma cells and immune suppressive leukocytes. Consistently, TCGA data analyses indicate that S100A4
expression is strongly correlated with primary and recurrent GBM patient survival, the mesenchymal subtype,
and immune-suppressive macrophage markers (such as CD163, CD206, and IL10). Importantly, our
unpublished results show that S100A4 in human and mouse glioma cells regulates expression of chemokines
and cytokines that control immune cell infiltration and polarization towards immune suppressive phenotypes.
Notably, knocking down S100a4 in glioma cells is sufficient to reprogram the immune environment and allow
dramatic increase in T-cell infiltration and activation in mouse gliomas. Furthermore, deletion of S100a4 in the
host mouse is also sufficient to reprogram the glioma immune landscape and extend survival (manuscripts in
preparation). Therefore, we hypothesize that S100A4 functions in both glioma and immune to promote
immune-suppressive environment in GBM through multiple mechanisms. To test this hypothesis, we will:
1) elucidate mechanisms through which S100A4 expression in glioma cells promotes local immune-suppressive
microenvironment in GBM (Aim 1); and 2) determine mechanisms through which S100a4 expression in immune
cells controls myeloid and T cell trafficking, polarization, and function (Aim2). Successful completion of this study
will reveal how S100A4 regulates glioma associated immune cell infiltration/polarization and identify a potential
novel immunotherapy target to treat GBM.

Public health relevance
Project Narrative Immunotherapy is a highly attractive treatment modality for brain cancer patients. Unfortunately, currently available immunotherapies are not effective in GBM because T cell infiltration and activation are inhibited by immune suppressive myeloid and glioma cells. Successful completion of this study will reveal how S100A4 expression in glioma and immune cells suppress T cell infiltration and activation and generate necessary preclinical data to evaluate whether S100A4 is a viable target as a novel immunotherapy to treat GBM.